Corticospinal neuron plasticity in response to developmental spinal cord axotomy.

PROJECT ABSTRACT
Spinal cord injury (SCI) is a devastating condition with limited treatment options due to the restricted
regenerative capacity of the mature central nervous system. Due to the heterogeneity of SCI along the
neuraxis, it impairs various corticospinal circuitry that affects motor control. The corticospinal tract (CST),
essential for voluntary movement, consists of diverse corticospinal neuron (CSN) subtypes, yet the
establishment of these distinct spinal-projecting neurons remains unclear. Recent findings from the Sahni lab
have identified early molecular differences in CSN subpopulations projecting to the cervical or thoracolumbar
spinal cord from cortical regions outside the classical motor cortex; however, this molecular map is incomplete.
Additionally, the lab has developed a novel microlesion technique to axotomize the developing CST, enabling
the study of CSN plasticity and circuit formation during development. Understanding how CSN projection types
and their postsynaptic spinal connectivity are established is crucial for developing strategies for functional
recovery after SCI. This proposal aims to investigate the molecular mechanisms underlying CSN development
and their long-range corticospinal circuits. My central hypothesis is that intrinsic regulators govern segmentally
distinct CSN identities and spinal synaptic circuitry. Specific Aim 1 will identify molecular regulators of CSN
diversity and determine whether segmental spinal targeting is governed by intrinsic mechanisms or target-
derived retrograde signaling. Specific Aim 2 will explore how route of axon extension influences synaptic
specificity and their implications for the evolution of cortical-motoneural connections and dexterity. To achieve
these aims, we will utilize mouse models and employ techniques such as viral tracing and microlesion
approaches. The findings will enhance our understanding of neurodevelopmental processes and may lead to
new therapeutic strategies for SCI recovery. With the support of this F32 fellowship, I will strengthen my
expertise in viral tracing, molecular profiling, and bioinformatics, preparing me to lead an independent research
program focused on leveraging developmental mechanisms to repair the injured nervous system.

Public health relevance
PROJECT NARRATIVE The corticospinal tract is one of the longest neural pathways in the body and plays a key role in voluntary movement, however, the specific corticospinal neuron (CSN) pathways that connect to different spinal segments, and how they form spinal connections, are still poorly understood. This project will investigate the molecular mechanisms that define distinct CSN subpopulations and the fundamentals of postsynaptic targeting in rerouted axons using a novel microlesion technique. These results will provide crucial molecular insights into CSN diversity, spinal connectivity and circuit plasticity, ultimately advancing therapeutic strategies to promote recovery and improve outcomes for individuals with spinal cord injuries and other related motor disorders.